Auto-sensing, instantaneous adaptive ranging OCT

Project Summary
Retinal blood vessels are affected by a wide range of relatively common eye diseases, including diabetic
retinopathy, glaucoma, macular degeneration, and retinal vein occlusion. To effectively diagnose and manage
these disorders, clinicians rely upon specialized cameras capable of imaging this retinal microvasculature.
Optical coherence tomography angiography (OCTA) is one of the most commonly used angiographic camera
technologies in both clinical and research settings. OCTA provides high-resolution, three-dimensional imaging
of retinal vessels down to the finest capillaries. However, due to technological limitations that limit OCTA’s
imaging depth range, it is challenging to use it to image the clinically significant peripheral retinal
microvasculature. In this work, we propose new technology to address this shortcoming. In Aim 1, we will
develop high-speed adaptive ranging OCTA instrumentation as a means for expanding by several-fold the
OCTA imaging depth range. To achieve this, we will leverage the latest advances in thin-film lithium niobate
integrated photonics to create a fast, tunable optical delay line, which is the essential enabling technology of
adaptive ranging. In Aim 2, we validate this technology by acquiring retinal angiograms over ultrawide fields in
human subjects. Study data will be used to establish the utility and feasibility of adaptive ranging OCTA and to
assess the imaging performance of OCTA systems built around the proposed integrated photonic tunable
optical delay line. If successful, this work will improve our ability to image the critical microvasculature of the
peripheral retina, which may improve the clinical management of multiple vision-threatening diseases.

Public health relevance
Project Narrative Cameras and imaging systems that reveal the retinal blood vessels are essential tools in the clinical management of multiple vision-threatening eye diseases. The proposed research will advance the capabilities of optical coherence tomography angiography (OCTA), one of the most common vascular imaging technologies in ophthalmology.